Vancouver Drug Users Study: The Impacts of Evolving Drug Use Patterns on HIV/AIDS

PROJECT SUMMARY / ABSTRACT
This competing renewal U01 application proposes an investigation of the impact of rapidly evolving substance
use patterns on HIV prevention and HIV-associated co-morbidities. We propose to undertake this work in
Vancouver, Canada, where, as in many areas in the US, exponential growth in synthetic opioid use has become
a health crisis. Accordingly, we seek to characterize emerging drug use patterns and the associated impacts on
engagement in HIV prevention and medication assisted treatments for opioid use disorder (MAT). We also aim
to assess willingness to use, uptake of, and adherence to new and emerging HIV-focused biomedical
interventions (e.g., pre-exposure prophylaxis [PrEP], microbicides). In Vancouver, PrEP has recently been made
available at no cost to those at high risk of HIV acquisition, including people who inject drugs (PWID). We further
aim to examine key HIV-associated co-morbidities, in particular pain and neurocognitive impairment, among a
combined sample of HIV-negative and HIV-positive PWID and the related impacts on substance use patterns,
engagement in HIV prevention and MAT. This project involves the continuation of the Vancouver Drug Users
Study (V-DUS; n = 1800), which is one of the longest-running prospective cohort studies of community-recruited
people who use illicit drugs (PWUD) internationally. The V-DUS is comprised of two nested cohorts following
HIV-negative street-involved drug-using youth aged 14-26 years and HIV-negative adult PWID since 1996. Our
study setting is a key innovative feature of the proposed work. Vancouver is a port city that continues to
experience high availability and prevalent use of a wide range of illicit drugs. It is home to one of the most
dramatic outbreaks of HIV among PWID and is now an epicenter of the ongoing synthetic opioid epidemic. In
response, a range of pioneering policies and programs specific to illicit drug use have been introduced, and
several of these are now being scaled up and/or considered in the US. For example, a broad set of MAT are
available for virtually free of charge through the universal healthcare plan and in a low threshold manner, which
allows us to examine MAT-related outcomes without the confounding effects of insurance schemes and
programmatic barriers associated with high-threshold provision of MAT. The V-DUS is also a member of the
C3PNO consortium and thereby ideally positioned to advance team science approaches. V-DUS has been highly
productive and is a globally unique, valuable resource for advancing HIV research and training future HIV
researchers. During the past grant cycle, >130 of >160 peer-reviewed publications have been led by >70 trainees.
The V-DUS is also harmonized with an ongoing NIDA-funded cohort of HIV-positive PWUD and therefore a key
control/comparison in work focused on HIV/AIDS among PWUD is possible. Given our environment and track
record to date, we are well positioned to generate important scientific evidence on HIV prevention and HIV-
associated co-morbidities thereby contributing to high and medium research priorities identified by the NIH Office
of AIDS Research and informing efforts to end the HIV/AIDS pandemic.

Public health relevance
PROJECT NARRATIVE The purpose of this proposed cohort study is to examine the impact of evolving substance use patterns on HIV prevention and HIV-associated co-morbidities. This study will involve 1800 participants in Vancouver, Canada, including HIV-negative adults who inject drugs and street-involved drug-using youth.